Muscular Dystrophy Specialized Research Center: Project 1

Project 1 Project Summary
The overall goal of our research is to elucidate the cellular and molecular mechanisms that underly
muscular dystrophies in order to facilitate the rational design of novel therapeutic strategies and quantitative
assays to assess target engagement and the effectiveness of therapeutic approaches. Our current research
focuses on the dystroglycanopathies, a group of congenital/limb-girdle muscular dystrophies caused by
defects in post-translational processing of the extracellular matrix (ECM) receptor α-dystroglycan (α-DG).
ECM proteins that contain laminin-G-like (LG) domains bind to α-DG via a unique heteropolysaccharide
[-GlcA-β1,3-Xyl-α1,3-]n called matriglycan. Genetic studies have shown that mutations in any one of at least
eighteen genes encoding enzymes required for α-DG post-translational processing lead to the absence of
or a reduction in matriglycan and thus impair α-DG receptor function. Although significant progress has
been made in the identification and characterization of dystroglycanopathy genes, we still do not fully
understand the biochemical and physiological function of matriglycan, or how its absence or reduction in
length causes muscular dystrophy. The overall objective of the proposed research is to provide mechanistic
insights into the role matriglycan plays in α-DG receptor function and in the pathophysiology of the
dystroglycanopathies. The overarching hypothesis of our research is that a thorough understanding of (a)
the shortened matriglycan structure and resulting α-DG receptor dysfunction in dystroglycanopathy patients
and (b) the mechanisms underlying the pathophysiology of the dystroglycanopathies, will lead to more
reliable diagnostics and novel therapeutic strategies. Specific Aim 1 will establish the relationship between
α-DG matriglycan length and laminin-binding properties of matriglycan on α-DG in control and
dystroglycanopathy patient fibroblasts and muscle biopsies. These studies will reveal abnormalities in the
post-translational processing of α-DG that result in shorter matriglycan with reduced affinity for laminin
leading to muscular dystrophy. Specific Aim 2 will define the biochemical regulation of matriglycan synthesis
and its role in the receptor function of α-DG. These studies will define the requirements for matriglycan
synthesis and how its synthesis is regulated by protein-protein and protein-sugar interactions. Specific Aim
3 will define novel mechanisms underlying the pathophysiology of the dystroglycanopathies and determine
the structure and laminin binding properties required to improve muscle function. These studies will use
myd mice with established dystrophic muscle pathology that are evaluated before and after LARGE gene
transfer. Collectively, these aims will provide an understanding of the pathological mechanisms underlying
dystroglycanopathies, which will be needed to develop a rationale for the design of novel diagnostic and
therapeutic strategies, as well as approaches to monitoring therapeutic engagement and efficacy.